Microbiota-mediated colonization resistance to Acinetobacter baumannii.

PROJECT SUMMARY
A healthy gut microbiota is a diverse microbial community that prevents colonization by invading pathogens,
termed “colonization resistance.” Acinetobacter baumannii is a global public health threat due to its high rates
of multidrug resistance and rapid spread in healthcare facilities by persistence in reservoirs including
asymptomatic colonization of the gut. Asymptomatic gut colonization by A. baumannii dramatically increases
the risk of clinical infection, emphasizing the potential impact on preventing A. baumannii infections by
disrupting colonization. A. baumannii gut colonization is associated with antibiotic treatments, altered nutrition
including tube feeding, illness, and hospitalization, suggesting there are multiple mechanisms to disrupt or
bypass microbiota-mediated colonization resistance. We developed a post-antibiotics mouse model of A.
baumannii gut colonization and determined that competition for nutrient niches is a major mechanism of
microbiota-mediated colonization resistance. An emerging paradigm is that colonization resistance to invading
microbes is conferred by occupation of all available nutrient niches by a complex microbiota that synergizes
with phylogenetically-related “keystone species” that encode similar metabolic functions to the pathogen.
However, A. baumannii metabolism fundamentally differs from the most closely related gut resident
Gammaproteobacteria. Therefore, it is not known which gut resident microbes may serve as keystone species
to synergize with a diverse microbiota to resist colonization to A. baumannii. We propose a model in which a
complex resident microbiota competitively excludes A. baumannii from preferred nutrient niches, and A.
baumannii overcomes microbiota-mediated colonization resistance by antibiotic disruption of the microbiota
community or nutritional perturbations. Experiments in this proposal will identify keystone species that
synergize with microbiota communities to confer colonization resistance, define nutrient niches from which A.
baumannii is excluded by intact or disrupted microbiota, and determine whether nutritional perturbations that
increase nutrient niches utilized by A. baumannii can overcome antibiotic resistance in the presence of an
intact microbiota (without antibiotics). We expect completion of these experiments will provide conceptual
advances to expand the paradigm of colonization resistance to invading opportunistic pathogens. Furthermore,
the findings from this proposal will lay the foundation for development of new strategies and treatments to
prevent A. baumannii colonization, disrupt spread, and prevent infections.

Public health relevance
PROJECT NARRATIVE Acinetobacter baumannii is an important multidrug resistant pathogen that spreads in healthcare facilities in part through asymptomatic gut colonization. A healthy resident microbiota confers colonization resistance to A. baumannii and other pathogens. Understanding the mechanisms by which the resident microbiota resists A. baumannii colonization has the potential to disrupt colonization and prevent healthcare facility outbreaks and infections.